Atlanta Network for Training In KUH Scientific Research (ATLANTIS)

PROJECT SUMMARY
This application is our vision for the “Atlanta Network for Training In KUH Scientific Research (ATLANTIS)”.
Our goal is to create a city-wide resource for training the next generation of researchers studying KUH-related
diseases. Emory will engage two of its close academic partners in metropolitan Atlanta, Morehouse School of
Medicine (MSM) and Georgia Institute of Technology (GaTech), to create a strategic multi-institutional alliance
designated to promote and foster KUH research training. ATLANTIS will establish new and strengthen existing
collaborative research networks, research training programs, and career development opportunities that will
foster a sustained interest in KUH diseases, thereby increasing the pipeline of these scientists into the
biomedical workforce. Our goals are: 1) provide the intellectual and research platform to attract and train the
next generation of new basic and clinical scientists in KUH research; 2) promote impactful interdisciplinary and
multi-institutional collaborations with the shared objective of KUH-related human disease investigation; 3)
promote KUH biomedical investigator success by enhancing the career development of young scientists; 4)
increase research and teaching collaborations in Atlanta by promoting interactions between Emory, GaTech,
MSM, and Spelman College, Morehouse Colleges and Clark Atlanta University (Historically Black Colleges and
Universities (HBCUs); and 5) increase the number of well-qualified underrepresented minority (URM) students
entering competitive careers in biomedical research. Aim 1 will develop an integrated, city-wide Training
Network for KUH research training (TL1 Training Core). Pre- and post-doctoral trainees will perform original
KUH research under the mentorship of a scientifically diverse preceptor pool. ATLANTIS will create a vibrant,
supportive and dynamic training environment to encourage trainees to answer important questions that directly
affect human health and disease. This rich experience will promote KUH research and prepare trainees for
their future research. Aim 2 will develop a dynamic Networked Program actively engaging TL1 and other
KUH trainees through peer networking, team science, and outreach efforts in KUH research (Network
Core). We will implement a cloud-based community software platform, ATLANTIS-Connect, explicitly designed
to foster, support, and supplement traditional in-person interactions and engage trainees at all career stages,
promote interest in KUH research, and develop peer-networking and peer-to-peer mentoring. Aim 3 will
develop an integrated Professional Development program that enhances trainee and preceptor
professional development (Professional Development Core). Trainees will participate in professional
development opportunities offered by the Office of Postdoctoral Education and the graduate programs at
Emory (Laney Graduate School), GaTech, and MSM. Our goal is to provide a meaningful research experience
coupled with individualized professional development. Preceptors will be required to obtain formal mentor
training, including mentoring of diverse trainees.

Public health relevance
Atlanta Network for Training in KUH Scientific Research (ATLANTIS) is an Institutional Network Award for Promoting Kidney, Urologic, and Hematologic Research Training in Atlanta. Our goal is to create an institutional resource for training the next generation of researchers for the study of kidney, urology, and hematologic (KUH) diseases. ATLANTIS will bring together trainees at multiple career stages who are interested in furthering their scientific research training and pursuing a career in biomedical research.